PREPARE BULK SUPPLIES OF ALLOANTIBODIES

1) Production of antibodies to mouse cell surface antigens, especially those specific to subsets of B-lymphocytes, T-lymphocytes and macrophages 2) distribution of these antibodies to qualified investigators worldwide.